Person-centered decision making: Developing a choice-based preference tool for transitions in dementia care

PROJECT SUMMARY
Sound decision-making about care during cognitive decline is a critical issue for the 5.8 million adults with
Alzheimer’s Disease and Related Dementias (ADRD) in the United States. Older adults (65 years and older)
with ADRD often are excluded from care decisions as their dementia worsens. Little is known about the
decision-making processes of older adults with ADRD concerning transitions from home-based care to long
term dementia care (e.g. nursing homes, assisted living, and memory care units), or how to best incorporate
older adults with ADRD in the decision-making process. The goal of this research is to advance our
understanding of decision-making processes, and the preferences that influence decision-making, for older
adults with ADRD and their caregivers. Through the Decision Making in Alzheimer’s Research (DMAR) study
we have (1) gained a detailed understanding of the complexities of dementia care decision-making and related
preferences through qualitative interviews with older adults with mild to moderate ADRD, caregivers, and
dementia care providers; (2) developed a dementia care preference elicitation tool for use in assessing the
preferences of older adults with ADRD and their caregivers through novel application of discrete choice
experiment (DCE) methodology in conjunction with visualization methods to ensure that the tool is responsive
to the needs of older adults with ADRD; (3) used the developed preference elicitation tool to ascertain
preferences for dementia care-related decisions among older adults with ADRD and caregivers. This
administrative supplement will provide funds to cover the unforeseen costs of conducting the analysis for DCE
data collected using our innovative study design. We will investigate the impact of the level of dementia on the
preferences of older adults with dementia and the consistency of those preferences over time. The goal of this
proposed research is to investigate novel strategies for keeping older adults with ADRD meaningfully involved
in decision-making, even as their dementia worsens.

Public health relevance
PROJECT NARRATIVE As older adults with Alzheimer’s disease and related dementias (ADRD) decline, they are increasingly omitted from decisions regarding care. The goal of this research is to keep older adults with dementia involved in decision-making through better understanding their decision-making processes and creating a novel tool designed specifically for older adults with dementia to identify their preferences related to transitions in care.